The Role of Non-Coding RNA Editing in MET Signaling in NSCLC

PROJECT SUMMARY
Lung cancer is the primary cause of cancer-related deaths in the U.S. Despite encouraging progress in creating
new therapeutics, most lung cancer patients develop resistance and succumb to metastatic disease. The
epidermal growth factor receptor (EGFR) is a receptor tyrosine kinase (RTK) that is frequently mutated in lung
cancer (10-50%). Several EGFR inhibitors have been developed to mitigate the transformative effects of mutant
EGFR. For example, gefitinib and osimertinib are tyrosine kinase inhibitors (TKIs) used for treating EGFR-
mutated non-small cell lung cancer (NSCLC). Unfortunately, despite the initial responsiveness of patients to
these drugs, a rapidly acquired resistance occurs mainly because of new genetic alterations, including
amplification of the hepatocyte growth factor receptor (MET).
Adenosine to Inosine (A-to-I) RNA editing represents 90% of all the RNA editing events in the cell and regulates
mRNA sequence, function, degradation, and structure. RNA editing has been observed in both coding and non-
coding genes, including miRs. Furthermore, coding RNA editing dysregulation has been recently associated with
cancerous phenotype and drug resistance, including against TKIs.
Recent high throughput interrogation of the human genome has allowed for the identification of miR editing
deregulation in cancer. However, the biological impact of edited non-coding RNAs (i.e., miRs) in lung cancer
progression and drug resistance remains largely unknown.
We preliminarily identified a reduction of A-to-I editing in position 5 of miR-411-5p in the tissues of lung cancer
patients. We determined that ed.miR-411-5p negatively affects the ERK1/2 pathway, directly targets MET, and
alters TKI drug resistance in NSCLC cell lines. Furthermore, it is reported that MET transcriptionally regulates
the expression of miR-222. We have also found that the miR-222 targets ADAR2, a member of the ADAR
proteins family, responsible for pre-mRNA and non-coding RNA A-to-I editing. ADAR2 also induces A-to-I editing
in miRs, including miR-411-5p. We found that ADAR2 is downregulated in lung cancer tissues and TKI resistant
tissue and cell lines and anticorrelates with miR-222 expression.
We hypothesize that miR editing dysregulation contributes to the pathobiology of lung cancer. Therefore, we aim
to globally evaluate the impact that ed.miR-411-5p has on NSCLC progression and TKI resistance. Then, we
also intend to investigate by RNA seq. if the ed.miR-411-5p induces ADAR2 expression and activity through
MET, ERK1/2, and miR-222 signaling repression with the scope of uncovering new post-transcriptional
mechanisms that regulate lung cancer progression and drug resistance.

Public health relevance
PROJECT NARRATIVE Until now, researchers have focused on examining the genetic mutations that drive lung cancer. At present, thanks to innovative sequencing technologies and computational tools, it is possible to investigate the molecular mechanisms that trigger lung cancer more deeply. By leveraging these modern tools, we aim to study the altered non-coding RNA post-transcriptional modifications, specifically A-to-I editing, in lung cancer progression and drug resistance with the scope of identifying new molecular targets and possibly new future therapies.